Comparing Dialysis Provision and Outcomes Between Medicare Advantage and Fee-for-Service Medicare

7. ABSTRACT
Most patients requiring dialysis for end-stage kidney disease (ESKD) obtain Medicare, with the majority
enrolling in fee-for-service (FFS or traditional) Medicare. Medicare Advantage (MA), when private insurers
coordinate Medicare benefits, is an alternative to FFS Medicare. However, prior to 2021, patients with ESKD
could only enroll prior to developing ESKD. Consequently, only 22% of Medicare patients with ESKD have an
MA plan, compared to 36% of Medicare patients without ESKD. The 21st Century Cures Act opened MA to all
patients with ESKD in 2021, and experts anticipate a large influx of enrollment into MA. Proponents of MA
argue that it results in better care-coordination of chronic diseases, leading to improved outcomes and reduced
costs in the non-ESKD population. It is unclear whether these findings extend to ESKD, and research on MA
ESKD outcomes are conspicuously sparse, despite its imminent importance. A key explanation is a lack of
available research data. The United States Renal Data System (USRDS), the dataset used for most dialysis
research, almost exclusively contains data on FFS Medicare. Additionally, because MA plans and dialysis
providers negotiate proprietary contracts for dialysis payment, MA dialysis reimbursements have substantial
variation, making comparisons across MA plans and providers difficult. Thus, researchers have focused
primarily on FFS Medicare. We will use a novel linkage between MA claims data and the USRDS dataset to
investigate outcomes in the MA dialysis population. In addition to being one of the first research projects to
broadly study dialysis in MA, our work will develop a research infrastructure that will make future research on
MA and ESKD more accessible. A key innovation is identifying a comparable unit of dialysis treatment (and all
related services) across MA plans and providers, and with FFS Medicare. In Aim 1, we will investigate whether
patients with MA accrue the benefits of improved care-coordination seen in non-dialysis populations with MA.
We will study whether MA results in improved outcomes at the start of dialysis (e.g., starting dialysis as
outpatients) and whether prevalent patients with MA and ESKD experience fewer hospitalizations or have
lower mortality. As a potential mechanism for improved care-coordination, we will explore whether MA patients
are more likely to receive extra outpatient dialysis sessions over the conventional thrice weekly dialysis
schedule. Aim 2 will assess heterogeneity in the MA market. We will study how market concentration at the
dialysis facility, the dialysis chain, and the MA plan levels modify our findings in Aim 1. For instance, dialysis
providers with few regional competitors may have more market power and, consequently, might be resistant to
care-coordination and cost-saving initiatives by MA plans. The proposed work will form the impetus for a larger
research effort, including an R01 application, aimed at studying the impact of the 21st Century Cures Act and of
expanding MA eligibility for the dialysis population in the United States.

Public health relevance
8. PROJECT NARRATIVE Patients requiring dialysis qualify for Medicare coverage, but prior to 2021, they were not allowed to enroll into Medicare Advantage (when a private insurance company provides and coordinates Medicare benefits) after starting dialysis. Since the start of 2021, the 21st Century Cures Act has allowed patients to enroll into Medicare Advantage after starting dialysis, and many patients are expected to switch from regular Medicare to Medicare Advantage. Because little is known about the effects of Medicare Advantage for patients who receive dialysis, we propose to study how dialysis provision and outcomes in Medicare Advantage differ from regular Medicare.